Admin Sup FACET: Family Dynamics and Child Neurodevelopment in Botswana

In sub-Saharan Africa (SSA) is home to 90% of the nearly 16 million children who are HIV-exposed uninfected
(CHEU). This population has been shown to be at increased risk of neurodevelopmental delays compared to
their HIV-unexposed peers. The World Health Organization and UNICEF advocate for use of the Nurturing Care
Framework, consisting of five facets of care – health, nutrition, responsive caregiving, safety from threats, and
opportunities for learning – a framework shown to optimize child neurodevelopment when fully implemented.
Given that families and caregivers are the primary source of a child's nurturing care, it is important to explore
associations between family structures, home environment, and child neurodevelopment, particularly among
families affected by HIV. In Botswana, a high prevalence HIV setting, one in four children under 15 years of age
are CHEU, and fewer than 10% of parenting couples are formally married. Given the fact that the Nurturing Care
Framework has never been programmatically implemented in Botswana and caregiving structures have not been
well described, understand caregiving within this unique context of low marriage rates and high HIV prevalence
and associations with developmental outcomes among CHEU is of critical public health importance. The
proposed FACET study (Family Dynamics and Child Neurodevelopment in Botswana) will leverage an ongoing
birth cohort within the FLOURISH Study (Following Longitudinal Outcomes to Understand, Report, Intervene
and Sustain Health of Infants, Children and Adolescents who are HIV-Exposed Uninfected; R33 HD103099;
Principal Investigators: Powis, Jao, Makhema) currently enrolling up to 300 pregnant persons, half of which are
living with HIV, and their infants to a) (Aim 1) to characterize patterns of household composition and family
dynamics for caregiving, and the role of nurturing care in promoting healthy neurodevelopment among children
in Botswana using a focus group discussion format; and b) employing a mixed-methods design (Aim 2), assess
the associations between child HIV exposure status, caregiver relationship factors, and child neurodevelopment.
The Caregiver Reported Early Developmental Index (CREDI), a parent-reported assessment tool that has been
validated for use across 26 countries, 17 of which are low-and-middle income countries, including Botswana, will
be administered to FACET participating mothers when their child reaches six-months of life. Simultaneously,
qualitative data will be collected from up to 30 mothers participating in a second round of focus group discussions
exploring how their relationships with their partners, paternal involvement in caregiving, home environment
factors (e.g., food insecurity, intimate partner violence), and child temperament may impact their caregiving.
Convergent parallel triangulation will be employed to jointly interpret quantitative and qualitative research
findings. Research is urgently needed to assess the combined impact of fetal HIV exposure and family structures
on child neurodevelopment.

Public health relevance
Approximately one million children who are HIV-exposed uninfected (CHEU) are born every year in sub-Saharan Africa, all of whom may be at higher risk of not meeting their neurodevelopmental potential. Leveraging the Botswana-based FLOURISH study, we will implement a nested mixed methods study designed to assess associations among child HIV exposure, caregiving factors, and early child neurodevelopment, as well as provide cultural context around family structures to ensure that quantitative findings are rooted in lived experiences. This research will fill a critical gap in knowledge about the collective influences of maternal HIV infection and parental relationships on child neurodevelopment in Botswana and will be used to inform interventions and normative guidance to high burden HIV countries to best support families affected by HIV. SPECIFIC AIMS